Administrative Supplement: Phosphoinositide Signaling in the Cytosol and Nucleus

Project Abstract
See Research Strategy. No changes.

Public health relevance
Project Narrative Not applicable - no changes.